Genomic risk in clinical care to promote preventive health in New York City patients

PROJECT SUMMARY
Building on our track record in genomic research, clinical trials, and genomic medicine in patients from NYC, we
propose to develop new frameworks to bring genomic risk into clinical care to promote preventive health.
Polygenic risk scores (PRS) are entering an exciting phase where they are poised to improve health outcomes
for myriad complex diseases through enhanced risk stratification and clinical decision making. However, major
challenges exist for clinical PRS implementation today, including issues of access to leading-edge genomic
technology, research, and testing, and barriers to uptake of medical recommendations. To address this, Mount
Sinai experts in statistical genetics and population genetics, with decade-long experience in building methods
for genetic risk prediction, will work together to rigorously develop robust clinical PRS tests. We will integrate
clinical PRS with standard clinical risk and family history information to generate genomic risk assessments for
up to 15 common diseases. Drawing on Mount Sinai's century of experience delivering excellent patient care,
we will recruit 2,500 adult and pediatric patients into a clinical trial. We will estimate participants' individualized
risk for each condition, and investigate the impact of genomic risk communication to patients and their physicians,
including patient understanding and uptake of recommended risk-reducing interventions. We
attitudes,
be
communication
will explore
barriers, and communication preferences related to genomic risk assessment. Knowledge gained will
used to guide the development of a new patient-facing digital platform supporting patient education and
of genomic risk. We will track patient engagement with their results through the platform, and
assess the impact of individualized genomic risk assessments on patient-reported psychosocial outcomes and
experiences. As of today, the path to effectively integrate genomic risk into clinical care in busy health systems,
is unclear. Hence, we are partnering with clinicians, scientists, industry experts, and community stakeholders to
explore a range of strategies to assess, communicate, and reduce disease risk, in order to maximize the
efficiency of genomic medicine delivery.

Public health relevance
PROJECT NARRATIVE Major challenges exist for including genomic information broadly into clinical risk assessment in routine clinical care, and issues of gaps in understanding clinical utility, and barriers to adopting medical intervention, slow implementation. We will recruit 2,500 NYC patients into a clinical trial to estimate individualized disease risk and investigate the impact of genomic risk communication to patients and their physicians, including trust and understanding of the information, uptake of recommended interventions, and psychosocial outcomes. We will work closely with our NHGRI, eMERGE, community, industry, and health system partners, and use lessons learned to inform future research and clinical strategies, maximize efficiency for genomic medicine delivery.